Serine/Threonine Phosphatases in Neurological Diseases

ABSTRACT. Phosphorylation is one of the most ubiquitous, reversible posttranslational modifications in cells,
and is a critical component of most signaling cascades. Strict temporal and spatial control are essential for the
fidelity of this process, as derailed signaling cascades lead to disease. Here, we continue our long-standing
effort to investigate signaling in neurons. If neuronal signaling goes awry, the most prominent results are well
known diseases, such as Alzheimer's disease and stroke. Recently, we successfully determined how the most
ubiquitous neuronal ser/thr protein phosphatase (PPP) calcineurin (CN) recruits its substrates. Namely, CN
binds regulators and substrates via CN-specific recruitment motifs (PxIxIT and LxVP). Further, we also
discovered that CN uses an active site recognition sequence (TxxP) to target substrate phosphosites, which,
in turn, drives vital biological functions. This is the first defined active site recognition sequence for any PPP,
transforming our ability to identify novel CN-specific phosphosites. Here, we will leverage our newly established
tools and discoveries to achieve three aims. First, we will establish the CN interactome and substratome in
distinct neuronal populations. This will enable us to demonstrate the diversity of CN functions in neurons, define
if they differ in response to stimuli as well as identify the molecular substrates that are necessary for these
changes to occur. Building further on the success of the previous funding period, we will also advance our
molecular understanding of CN substrate recruitment by studying two critical CN substrate signaling platforms:
CN-AKAP5 and CN-TAK1. Specifically, we will show that the these signaling platforms utilize multiple,
competing PxIxIT/LxVP motifs to recruit CN via different proteins and show how these distinct mechanisms
define CN substrate dephosphorylation efficacy. Critically, our preliminary data suggest that posttranslational
modification of AKAP5 modulates CN control of PKA activity and ultimately receptor regulation. Finally, we
have also recently confirmed our prediction that the transforming growth factor-β activated kinase 1 (TAK1)
binds directly to CN. However, unexpectedly the TAK1 regulator TAB2 also binds directly to CN via different
LxVP and PxIxIT motifs. We will investigate the mechanisms and consequences of this interaction on CN
recruitment and TAK1 function. The modes of action and regulation of CN in the AKAP5 and TAK1 signaling
platforms are unexpected and highlight the broad variety of mechanisms used to regulate CN activity. Taken
together, the proposed studies leverage a powerful integrated approach that combines atomic resolution
techniques with biochemical and cell biology experiments to obtain novel insights into the molecular
mechanisms used to direct CN activity. Because CN has critical roles in human diseases generally, and in the
brain specifically, and because CN is the only successfully therapeutically targeted PPP (CN is the target of
the blockbuster immunosuppressants cyclosporin A and FK-506), our proposed work will provide a critically
needed molecular and cellular understanding of CN activity and regulation in neuronal function.

Public health relevance
Project Narrative: The protein phosphatase calcineurin (CN) is a ubiquitous ser/thr protein phosphatases, but highly enriched in the brain. Despite decades of research, most CN substrates are still unknown. We have assembled a team of researchers that will be able to overcome this impediment and to allow for novel biological insights to be gained.